CELL CYCLE REGULATORY PROTEIN TEMPORAL &SPATIAL PROPERTY: GI TUMORIGENESIS

With the aid of transgenic mice(in collaboration with Dr. Jeffrey Gordon,Washington University) expressing proteins,(p53,Kras and T-antigen) involved in tumorigenesis, in conjunction with cDNA's related to cell-cycle regulation(in collaboration with Dr. David Beach, Cold Spring Harbor); I intend to investigate the relationship among proteins, substrates and ligands in an attempt to elucidate temporal and spatial relationships essential for normal cellular proliferation and differentiation.